Characterizing the Role of NOTCH2 in Neuroendocrine Tumors

PROJECT SUMMARY
Pancreatic neuroendocrine tumors (pNETs) are the second most common malignancy of the pancreas, with an
overall survival of 3.6 years and successful surgery the only treatment offering potential for cure. However,
around 40-95% of pNETs are metastatic at the time of initial diagnosis, with local recurrence within the
resection bed as the norm. Furthermore, patients with liver metastases from pNETs often have debilitating
symptoms such as uncontrollable diarrhea, flushing, skin rashes, and heart failure. There are few systemic
therapies that have proven to be clinically useful, and those that have still bear widely variable response rates
and have poor side effect profiles. The goal of this proposal is to determine the role of Notch2 in the
proliferation, metastasis, and hormone-secreting phenotype of NETs, and evaluate Notch2 as a
predictor of patient outcomes. Preliminary data from our lab suggests that overexpression of Notch2 results
in an increase of the proliferative rate of NET cells, while decreasing their hormone secretion. Our data also
suggest that Notch2 is upregulated in metastatic pNETs compared to primary tumors. Seminal data from one
of the largest genomic studies to date on pNETs has also identified Notch2 as a key master-regulator of pNET
metastasis, representing a key convergence of dependencies required for disease progression and the
establishment of metastasis. Therefore, it is my hypothesis that Notch2 functions in an oncogenic role in
NETs and drives tumor progression, resulting in a more aggressive phenotype and portending worse
patient prognosis. To evaluate this hypothesis, we will conduct phenotypic characterization (proliferation,
hormone production, migration) on Notch2-overexpressing pNET cell lines that have been transiently and
stably transfected. We will similarly evaluate pNET cell lines with Notch2 knockdown via siRNA, as well as
stable knockout pNET cell lines generated using CRISPR-Cas9. We will then conduct similar studies in vivo
using a liver metastasis mouse model whereby Notch2-overexpressing and Notch2 pNET cell lines are injected
into athymic mice. Using this model, we will evaluate tumor growth and metastasis via microCT, in addition to
hormone secretion over a 16-week period. We will then conduct endpoint analysis of tumors and mouse
organs. Lastly, we will immunohistochemically analyze the expression of Notch2 using pNET tissue
microarrays derived from human patients that have undergone surgical resection at the University of Alabama
at Birmingham and evaluate the relationships between the expression of Notch2, Notch2 pathway
components, and various patient outcome measures. This study will yield valuable information on the effects of
Notch2 in pNETs that can help to guide future targeted therapeutic efforts and inform an understanding of
pNET biology.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (PROJECT NARRATIVE) Patients with pancreatic neuroendocrine tumors (pNETs) often have few symptoms before tumors have metastasized, hence most patients are diagnosed with late-stage disease for which there are few effective therapies. The incidence of pNETs increases yearly, but the development of newer and more effective therapies is still limited by our understanding of the biology of pNET tumorigenesis and progression. Modulation of the Notch2 signaling pathway is a promising approach for treating pNETs, and further characterization of the role of the Notch2 pathway in pNETs may deepen our understanding of NETs while facilitating the development of novel therapies.